University of California Health Participation in the National COVID Cohort Collaborative (N3C)

PROJECT SUMMARY Through this supplement, we will orchestrate a collective effort across the five CTSA Hubs at the University of California (UC) Health to contribute data to, and become a strategic partner of, the National COVID Cohort Collaborative (N3C). By combining the data resources and research informatics expertise at UC Davis, San Francisco, Los Angeles, Irvine, and San Diego, UC Health is uniquely positioned to provide high-quality clinical data of diverse patient populations across the State of California to help N3C fulfill its mission to “build a centralized national data resource that the research community can use to study COVID-19 and identify potential treatments as the pandemic continues to evolve.” The proposed work will leverage an existing UC- wide initiative on curating the UC COVID Research Data Set (UC CORDS), a continuously updated HIPAA Limited Data Set that contains comprehensive clinical information of all patients tested for COVID-19 at any UC Health facility. To ensure high-quality and timely data delivery, we will create a UC-wide governance structure to establish a master Data Transfer and Use Agreement (DTUA) with NCATS on behalf of all five UC CTSA Hubs, in addition to coordinating research ethics reviews. We will also create an informatics task force involving key stakeholders at each UC CTSA Hub to coordinate site-level data work. Data aggregation, quality assurance, and submission will be performed by the UC Health Data Warehouse (UCHDW) team at the Center for Data-Driven Insights and Innovation (CDI2) in the UC Office of the President. Glossary ACT Accrual to Clinical Trials CDI2 Data-Driven Insights and Innovation CDW Clinical Data Warehouse CMBI Center for Biomedical Informatics COVID-19 Coronavirus Disease 2019 (COVID-19) CTSA Clinical and Translational Science Awards DTUA Data Transfer and Use Agreement EHR Electronic health records i2b2 Informatics for Integrating Biology and the Bedside N3C National COVID Cohort Collaborative OMOP Observational Medical Outcomes Partnership PCORnet National Patient-Centered Clinical Research Network SHRINE Shared Health Research Information Network UC BRAID University of California Biomedical Research Acceleration, Integration, and Development UC CORDS University of California COVID Research Data Set UC Davis CTSC University of California, Davis Clinical and Translational Science Center UC Irvine ICTS University of California, Irvine Institute for Clinical and Translational Science UC ReX University of California Research Exchange UCHDW University of California Health Data Warehouse UCLA CTSI University of California, Los Angeles Clinical and Translational Science Institute UCSD ACTRI University of California, San Diego Altman Clinical and Translational Research Institute UCSF CTSI University of California, San Francisco Clinical and Translational Science Institute

Public health relevance
BLANK